Mapping proximal and distal splicing-regulatory elements

Mapping proximal and distal splicing-regulatory elements
PROJECT SUMMARY
Alternative splicing (AS) of precursor mRNA is a molecular mechanism that allows single genes to generate
multiple transcript and protein isoforms, providing a major driving force of molecular diversity in mammals
including humans. AS is tightly regulated temporally and spatially to determine the types and level of protein
products expressed in specific cellular contexts. Such regulation is dictated by numerous splicing-regulatory
elements (SREs) in the alternative exon or flanking introns that are recognized by RNA-binding splicing factors.
Aberrant splicing caused by disruption of SREs is implicated in an expanding list of genetic diseases ranging
from neurological disorders to cancer, as well as phenotypic variation in human populations. This is reflected in
recent findings that splicing quantitative trait loci (sQTLs) are as prevalent as gene expression QTLs, and they
are similarly enriched in genetic variation associated with human diseases identified by GWAS. Despite the
remarkable progress of the field, identification of causal splicing-disrupting variants has been severely impeded
by the lack of comprehensive SRE annotations in the human genome, as compared to similar maps of
transcriptional or epigenetic regulatory elements. To fill in this tremendous gap, this study proposes an unbiased,
high-throughput screening approach to map functional SREs, including those in distal regions that are largely
overlooked by current studies. If successful, this platform technology will facilitate the genomic research
community to study gene expression regulation, understand genotype-phenotype relationships, and interpret the
impact of genetic variation in human diseases.

Public health relevance
PROJECT NARRATIVE This proposed study aims to develop a high-throughput screening method to map noncoding functional elements underlying regulation of alternative splicing. Disruption of these splicing-regulatory elements has been implicated in an expanding list of human genetic diseases. Results from this study may provide tools and resources to better understand disease mechanisms and develop potential therapeutic approaches.